Community Engagement and Health Equity Core

PROJECT SUMMARY – Community Engagement and Health Equity Core
The overall goal of the Community Engagement and Health Equity (CEHE) Core is to build the capacity of
diabetes investigators and community stakeholders to conduct high-impact community-engaged research
(CEnR) that promotes health equity. As the nation's third largest city, Chicago is widely known for its segregated
neighborhoods with stark social and structural inequities that contribute to health disparities. Diabetes represents
an especially relevant and poignant example, with a prevalence that ranges from 3.8% in Chicago's wealthiest
community area to 19.7% in one of its poorest neighborhoods. To eliminate these unacceptable disparities,
investigators and community stakeholders must partner to conduct diabetes translation research that has real-
world impact. CEnR represents a promising approach to promote diabetes health equity by facilitating an
understanding of the lived experiences of community members, prioritizing research questions of importance to
communities, tailoring interventions for cultural salience, and honing dissemination strategies. The Chicago
Center for Diabetes Translation Research (CCDTR), and its leaders from the University of Chicago (UC) and
Northwestern University (NU), are national experts in CEnR and health equity, engaging diverse communities
throughout Chicago and beyond in groundbreaking research that has produced meaningful improvements for
individuals and neighborhoods locally, regionally, and nationally. The CEHE Core leverages a rich array of
combined institutional resources and community partners from two of the nation's premier universities, in a truly
citywide, community-engaged approach for promoting diabetes health equity. In Aim 1, CEHE will consolidate
numerous existing educational opportunities focused on CEnR, offering them to both investigators and
community stakeholders to build their collective capacity to conduct high-impact diabetes translation research.
Aim 2 offers consultative services to enhance community and stakeholder engagement in CCDTR-supported
research. This aim also includes creating a novel Diabetes Stakeholder Database to catalyze new diabetes
translation research partnerships. In Aim 3, CEHE will leverage existing resources for disseminating research
products to communities and other stakeholders who can translate them into practices and policies that promote
diabetes health equity. The CEHE Core builds on a long history of prior successful diabetes-related CEnR and
health equity research at UC and NU, combining these leading institutions' faculty expertise, educational
opportunities, and community partnerships. This exciting partnership in CEHE is responsive to RFA-DK-20-002
by: 1) enhancing educational opportunities in CEnR and health equity that will prepare both academic
investigators and community stakeholders to conduct impactful diabetes translation research; 2) fostering
collaboration between academic investigators and a large array of community stakeholders with experience
translating research into practice; and 3) demonstrating established reach into diverse communities across the
entire city of the Chicago and beyond.